Core E - Comparative Data Analytics Core

Project Summary – Comparative Data Analytics Core
The Comparative Data Analytics Core (Analytics Core) will provide not only high-level customized statistical
support for basic science investigators studying aging and energetics in diverse model organisms at UAB, but
also a venue for development of de novo methods specially for such research and a platform for the
dissemination of such methods to the aging research community at large. The core leadership comprises
statistical scientists with decades of combined history of studying the interface of aging, energetics and body
composition. They bring not only their statistical expertise, but their experience with and zeal for the science of
comparative studies at the interface of aging and energetics.
The need for specialized statistical expertise and support in aging research is clear. Statistical analyses of aging
research data provide many challenges. Aging research involves longitudinal analyses and modeling the
dependency of multiple observations taken over time, and accommodating the missing data that commonly
occurs with longitudinal studies. Left, right, and interval censoring add further complexities with time-to-event
(e.g., survival) outcomes. Statistical approaches in comparative biology face challenges such as phylogenetic
dependence among model residuals that complicate inference.
Non-statistician researchers benefit from the support and involvement of statistical scientists who are deeply
involved in the subject matter, who can tailor methods to the situation at hand, who work with the biologists from
the beginning as an engaged part of the research team, who can discuss the methods with the biologists and
explain the statistical procedures and who can develop new statistical methods for specific needs.
To that end, the Analytics Core offers the following specific aims:
Specific Aims 1/2: To provide statistical support for 1) UAB investigators and 2) non-UAB investigators
studying the comparative energetics of aging, including traditional, specialized, and bespoke methods.
Specific Aim 3: To conduct high-level statistical investigations of secondary data to answer questions
about the comparative energetics of aging.
Specific Aim 4: To develop and evaluate statistical methods needed in the field of the comparative
energetics of aging.
Specific Aim 5: To provide reproducibility, verification, and transparency support for aging researchers.
An investment in this core will achieve dividends by catalyzing more informative and rigorous research on aging
within the UAB NSC and for the community of aging researchers at large.
1 of 1